CNS Mechanisms Linking Exercise Training with Energy Balance and Metabolism

ABSTRACT
We have assembled a multidisciplinary team of investigators to investigate how the brain and key peripheral
metabolic signals regulate feeding and glucose homeostasis following exercise. In particular, we have
developed a program focused on using unique, genetic mouse models to understand why exercise training
improves multiple metabolic parameters including insulin sensitivity and changes in body composition. We
propose a set of projects that revolve around the hypothesis that several of these exercise-associated effects
are mediated by changes in key brain circuits. The investigators involved in this application, Elmquist, Betley
Zigman, and Williams bring distinct and synergistic expertise to the table. The Elmquist/Betley group will
investigate the role of the ventromedial hypothalamus nucleus (VMH) neurons in the regulation of metabolic
changes induced by exercise. The Zigman group will investigate the physiological importance of ghrelin
signaling in regulating responses to exercise. The Williams group will investigate the changes in fundamental
cellular properties of hypothalamic neurons following exercise training These three tightly interwoven Projects
will address a number of new aspects of inter-organ communication between the peripheral tissues and critical
regions in the brain. Three Cores will support the three Projects in these efforts: A) Administrative Core; B)
Mouse Exercise and Metabolic Phenotyping Core and the C) Neuroanatomy/Histology/Brain Injection
Core. In summary, these innovative and synergistic studies will increase the understanding of how exercise
training regulates key peripheral metabolic signals via changes in central nervous system circuits.

Public health relevance
NARRATIVE Studying the molecular underpinnings of exercise may provide insights to a wide range of diseases associated with physical inactivity, such as result from physical inactivity, such as obesity, type II diabetes mellitus, cancer, and hypertension. We believe that exercise causes fundamental changes in the brain, which in turn, lead to changes in whole-body metabolism. We hope to pursue these studies with the combined help of all four participating laboratories and Cores, taking advantage of tools and expertise contributed by each of the investigators.